Mechanisms for the regulation of novel lipids in vivo

Project Summary/Abstract:
Research: Insulin resistance is a major cause for type 2 Diabetes (T2D) and is implicated in many life-
threatening complications of T2D. A better understanding of the molecular mechanisms for insulin resistance is
essential to develop potent and safe insulin sensitizers, which could reduce the social and economic burden of
metabolic diseases. Our lab discovered a novel class of anti-inflammatory and anti-diabetic lipids, Palmitic Acid
Hydroxy Stearic Acids (PAHSAs). PAHSA levels strongly correlate with insulin sensitivity in humans and are
down-regulated in adipose tissue (AT) from insulin resistant subjects. PAHSAs are potent hepatic and systemic
insulin sensitizers in obese T2D mice. This project will identify the mechanisms for the regulation of PAHSAs in
altered metabolic states in vivo and the enzymes mediating their biosynthesis and degradation, providing novel
strategies to prevent or treat T2D. Specific Aim1: To determine the mechanisms that regulate PAHSA levels in
vivo. Specific Aim2: To identify candidate enzymes for PAHSA biosynthesis and degradation in our unique
genetic mouse models of altered glucose homeostasis. Specific Aim3: To identify natural genetic drivers of
PAHSA metabolism using the established profiling of the natural genetic variation among 8 mouse strains to
mimick human variation. These studies will uncover novel pathways at the crossroad between AT lipogenesis
and insulin sensitivity that can be manipulated to prevent or treat T2D.
Candidate’s career development plan and career goals: I am highly committed to elucidate the mechanisms
for insulin resistance and T2D with the ultimate goal of expanding the therapeutic armamentarium for T2D. During
my postdoctoral training in Dr. Barbara’s Kahn lab, I became interested in the connections between AT
lipogenesis and systemic insulin sensitivity. During the K01 award, I will acquire the necessary skills to study
lipid metabolism in vivo combining innovative and powerful multiomic approaches and molecular biology. The
studies in this K01 proposal will be conducted under the mentorship of Drs. Kahn and Saghatelian with the
guidance of an outstanding scientific advisory committee (Drs. Alan Attie, Joshua Rabinowitz, and Evan Rosen),
who are highly committed to my development into an independent scientist. Periodic meetings with these experts
will center on experimental design, discussion of results, future directions, and preparation of R01 and R03
grants. My long-term career goal is to become an NIH-funded independent scientist. The training received during
this K01 award is necessary for my successful transition to independent investigator in the Academia.
Environment: The BIDMC Endocrine Division is the ideal site for training of young scientists towards a path of
independence because it offers unparalleled opportunities for interactions with leaders in the fields of diabetes
and metabolism. Graduates from this Division have made transformative discoveries that open new trajectories
for diabetes and metabolism research.

Public health relevance
Project Narrative: Type 2 Diabetes (T2D) and several life-threating complications of T2D share, as a major cause, insulin resistance for which the etiology is not fully understood, thus limiting the ability to develop highly effective and safe insulin- sensitizing medications. Palmitic Acid Hydroxy Stearic Acids (PAHSAs), endogenous lipids with potent insulin- sensitizing effects in obese T2D mice, are highly associated with insulin-sensitivity in humans and markedly down-regulated in the adipose tissue and serum of insulin resistant individuals. Combining cutting-edge, unbiased and synergetic approaches, we will determine the mechanisms responsible for the down-regulation of PAHSAs in insulin-resistant individuals and identify the enzymatic program responsible for the synthesis and degradation of PAHSAs in mammalian cells, providing novel therapeutic avenues to prevent or treat insulin resistance and T2D.